Shared Resource in Cellular Imaging

Abstract
The vision of the Cellular Imaging Core of the Huntington Medical Research Institutes (HMRI) is
to provide investigators access to cutting-edge technology, and expert technical support for
microscopic observation and analysis of cellular anatomy and physiology that is essential for
diverse aspects of our multidisciplinary biomedical research. A major gap in our current imaging
systems is acquiring a balance between image quality, throughput, and accessibility. Due to
these limitations, researchers at HMRI need to outsource their brightfield and
immunofluorescence needs to costly and busy core facilities. Here we propose to overcome
these workflow and high-cost limitations by proposing an all-in-one fluorescence microscope,
BZ-X800 that has multiple features and will strengthen the cell biology projects in various labs at
HMRI. The instrument will be housed in the Cellular Imaging Core facility designated to the
second floor of the newly built research building and will accelerate research supported by 5
NIH R01 grants, on robust and quantitative fluorescence and brightfield imaging. The Core will
be shared by multiple investigators and will strengthen the undergraduate, STEM and
postdoctoral educational programs at HMRI. It will be critical for meeting the goals of ongoing
NIH-funded projects, as well as planned future projects. This all-in-one microscope will facilitate
our research at unprecedented speeds, and forge new avenues for understanding and
treatment of psychiatric, neurological, and heart disease.

Public health relevance
Narrative Research generated with the contributions of the Cellular Imaging Core is relevant to public health because it will result in new insights into the etiology, pathogenesis, and treatment of three categories of diseases -1) psychiatric (autism, schizophrenia, anxiety, depression and mood disorders), 2) neurological (epilepsy, migraine, Alzheimer’s disease) and 3) heart disease. The BZ-X800 All-in-one fluorescence microscope will be dedicated to the NIH funded projects aimed at evaluation of brain and heart pathology, and to uncover new treatment strategies for patients.